Exploring Collateral Lethality for Development of Cancer Therapeutics

Project Summary
Pancreatic cancer remains the most lethal disease with no effective therapeutics. We have recently made
conceptual advances in targeting signature genomic deletions, a hallmark of human cancers. We
demonstrated earlier that passenger deletions could confer cancer cell specific vulnerabilities, which we
termed “Collateral Lethality”. We deployed this concept in targeting the SMAD4 deletion, which occurs
frequently in pancreatic cancer, and have identified malic enzyme (ME) 3 as a target for collateral lethality in
SMAD4-deleted pancreatic tumor cells harboring adjacent deletion of malic enzyme 2. We unexpectedly
discovered that mitochondrial malic enzymes are required for the uptake of branched chain amino acids
(BCAAs) in pancreatic cancer, which has been implicated as a diagnostic plasma marker for early detection of
pancreatic cancer. Our overall goals are: to validate ME3 as a therapeutic target for pancreatic cancer in vitro
and in PDX models (Aim 1) and in vivo using chimeric PDAC model (Aim 2); and to identify useful therapeutic
agents that specifically target ME2 deleted cells (Aim 3). Our goals align well with the NCI directive on
“Scientific Framework for Pancreatic Ductal Adenocarcinoma.”

Public health relevance
Project Narrative Pancreatic cancer will soon become the second leading cause of cancer death behind only lung cancer. Using an innovative collateral lethality concept developed in our lab, we have identified novel targets for pancreatic cancer and plan to develop therapeutics against this deadly disease using tools proposed in this grant application.